SHARE: Simplifying Human Subject Data Sharing for Alcohol Researchers

Abstract
The National Institute of Mental Health (NIMH) Data Archive (NDA) collects and shares de-identified human
subjects data from hundreds of NIH-funded research projects across many mental health-related scientific
domains with qualified researchers. A new NDA repository is created for the National Institute on Alcohol
Abuse and Alcoholism Data Archive (NIAAADA) and will serve as the portal for NIAAA-related data submissions
and access. The NIAAA data-sharing policy (NOT-AA-19-020) released in July of 2019, requires that—
beginning in 2019—all NIAAA grant applications involving human subjects must include plans for the
submission of study data to NIAAADA. The first wave of submission to NIAAADA is expected in January of 2021.
Many obstacles exist for alcohol researchers to comply with this policy, especially for those with limited budget
and information technology support. To submit the study data, researchers have to comb through large and
complex NDA data definition files, often filled with inconsistencies and inaccuracies, to find the measure items
that they need, and then map their data to the right fields in the right format in a given data template. This
process often requires researchers to manipulate their data by-hand or with complicated scripts, and is error
prone, time-consuming, and requires certain technical skills. Our ultimate goal is to provide a nearly-automated
process for the submission of alcohol research data into the NIAAADA so that the data submission can be
performed accurately and efficiently by alcohol researchers with minimum IT knowledge and resources.
We propose to develop and validate the Share HumAn REsearch (SHARE) platform to address the unmet
need for assisting alcohol researchers with the submission of study data to NIAAADA. SHARE does so by
offering the SHARE Measure Library of pre-defined standard measures that are already mapped to NDA data
dictionaries. Alcohol researchers need to only select the measures that they want to use for their studies and
let SHARE do the rest for data submission to NIAAADA.
Phase II aims include: 1) Platform and measure development. In Phase II we will continue using a user-centric
design process and the latest e-technologies to develop SHARE, and we will extend to 200 measures in both
English and Spanish (when available). 2) Pilot evaluation. There will be 4 NIAAADA submission waves during
the two-year Phase II period. We plan to align both Aim 1 and Aim 2 activities to these 4 submission waves
and recruit five projects in each wave to compare the performance of SHARE vs. NDA. A total of 20 pilot
projects will be recruited and randomized to use either SHARE or NDA for NIAAADA submission. The time and
cost for data preparation and submission will be tracked, and the accuracy of submitted data assessed. We
hypothesize that compared to NDA, SHARE will perform significantly better in terms of reduced time and cost
improved data accuracy.

Public health relevance
Project Narrative The NIAAA data-sharing policy (NOT-AA-19-020) released in July of 2019, requires that—beginning in 2019— all NIAAA grant applications involving human subjects must include plans for the submission of study data to NIAAADA, a central data archive to store and share de-identified human subject data from NIAAA-funded research studies. The first wave of data submission to NIAAADA is expected in January of 2021. Many obstacles exist for alcohol researchers to comply with this policy, especially for those with limited budget and information technology support. To submit the study data, researchers have to comb through large and complex NDA data definition files, often filled with inconsistencies and inaccuracies, to find the measure items that they need, and then map their data to the right fields in the right format in a given data template. This process is error-prone, time-consuming, and requires certain technical skills. Our ultimate goal is to provide a nearly-automated process for the submission of alcohol research data into the NIAAADA utilizing pre-defined standard measures so that the data submission can be performed accurately and efficiently by alcohol researchers with minimum technology knowledge and resources.